Relationship between the ontogeny of immunosuppression and increased susceptibility to infection during infancy

ABSTRACT Immaturity of the immune system in neonates and infants represents an underlying factor for increased susceptibility to infection that threaten childhood. However, the exact mechanisms responsible for immaturity of the immune system remain to date uncharacterized. Work from my laboratory provided evidence that immaturity of Natural Killer (NK) cells is orchestrated by TGFβ. We demonstrated that NK cells are able to complete maturation early in life if TGFβR signaling is blocked. A point of crucial consequence of this advantage is efficient control of cytomegalovirus infection in infant mice with NK cells lacking TGFβR signaling. The overall goal of this proposal is to elucidate the cellular and molecular mechanisms by which TGFβ imposes constraints on NK cell immune maturation during infancy and to identify the factors upstream and downstream of TGFβR signaling that dictate the fate of infant NK cell immaturity. Three specific aims will be addressed in this proposal: (1) define the make-up of TGFβ signaling pathway in infant NK cells, (2) determine whether hematopoiesis in early life is conducive to higher availability/activity of TGFβ, and (3) establish the relationship between the prevalence of neonatal suppressor cells and immaturity of NK cells during infancy. The continuing high global burden of infections in children elucidates the need for on-going basic and translational studies in the area of neonatal and infant immune ontogeny. Distinct early life immune ontogeny will certainly have direct implications for current and future pediatric therapies. In that regard, this project holds substantial promise in unraveling new strategies that can be applied to unlock the NK cell deficit in early life, a deficit that was originally thought intangible.

Public health relevance
NARRATIVE Does your child seem to catch a new cold every month? Are you struggling to keep the sniffles away? Are you wondering why your child immunity is so fragile? It's been believed that, like walking and talking, fighting infections is something children will develop when they get older. But a study from my laboratory suggested that the natural ability to fight infection is there early on. We have identified a key signaling factor -TGFβ- that prevents Natural Killer (NK) cells from completing their maturation during infancy. When we blocked TGFβ in mouse NK cells, we discovered that NK cells from infant mice were able to complete maturation and to protect infant mice from viral infection. The overall goal from this project is to elucidate the relationship between the ontogeny of immunosuppression and the increased susceptibility to infection during infancy. OMB No. 0925-0001/0002 (Rev. 08/12 Approved Through 8/31/2015) Page Continuation Format Page